RECOMBINANT IMMUNOTOXIN PRODUCED IN MAMMALIAN CELLS

The goal of this research program is to engineer an express, in mammalian cells, a whole antibody/ricin immunotoxin with therapeutic qualities that exceed bacterially-produced recombinant immunotoxins. Ricin is a plant toxin comprised of a non-toxic B-chain that attaches the toxin to cell surfaces and facilitates penetration of cell membranes by the toxic A- chain, an N-glycosidase that catalytically inactivates mammalian ribosomes. The two-chain subunit structure of ricin presents the unique opportunity to express the non-toxic B-chain as a fusion protein with a full length heavy chain of an antibody in a mammalian cell such as a non- secreting myeloma. Once the Ig/B-chain fusion hybrid is purified, it can be re-associated with ricin A-chain to form a recombinant immunotoxin that can be used to treat diseases of clonogenic origin. Currently, recombinant immunotoxins are made by fusion of bacterial toxins to antibody fragments, which can only be produced in bacteria. These single-chain toxins have very brief half-lives in vivo, and pre-existing antibodies to toxins like Pseudomonas exotoxin and diphtheria toxin preclude their use in some patients. A recombinant ricin immunotoxin expressed in myeloma employs whole Ig, which has a long serum half-life (weeks) that could produce increased therapeutic efficacy in patients. A recombinant ricin immunotoxin that incorporates whole antibody has therapeutic potential in the treatment of cancer, graft vs host disease, transplant rejection, auto-immune disease and allergies.